Structure, Function, and Antibody-based Modulation of GPR126: Regulation of an Adhesion GPCR by its Extracellular Region

Project Summary/Abstract
Cellular adhesion is a process critical for the development of all organs and is mediated by the adhesion family
of cell-surface G protein-coupled receptors (aGPCRs). aGPCRs are a large, understudied group of receptors
that link cell adhesion to cell signaling. aGPCRs regulate organ development, nervous system development and
function; they are dysregulated in developmental disease, neurological disease, and cancer. aGPCRs stand as
the next generation of drug targets for these indications, yet drug development is hindered by an incomplete
understanding of the molecular basis for aGPCR function. aGPCRs are defined by their enigmatic multidomain
extracellular regions (ECRs) which are hypothesized to mediate ligand binding and receptor activity. Our
hypothesis is that the ECR can affect basal receptor signaling activity by occupying conformations that modulate
the seven-transmembrane region of the aGPCR. This proposal aims to discover the structural basis of the
regulation of an aGPCR by its ECR, the key gap in aGPCR biology. This will be done using a model receptor,
GPR126. GPR126 is linked with peripheral nerve myelination and spine development. GPR126 dysregulation is
associated with developmental disease and cancer. GPR126 has a large multidomain ECR with two splice
variants that promote low and high signaling activity. Our lab previously determined the structure of one GPR126
splice variant which represents the low activity conformation of this ECR. I have further built the groundwork for
this proposal by purifying the high activity GPR126 splice variant and obtaining protein crystals. I have also
optimized a signaling assay that will allow me to interrogate the effect of point variations in the ECR on GPR126
signaling activity. I propose three Specific Aims that will help interrogate the structural basis GPR126 ECR
function: First, I aim to determine a high-resolution structure of the high activity GPR126 splice variant. Second,
I will test disease-associated GPR126 variations for their ability to alter activity using functional assays and I will
collaborate with the laboratory of Dr. Kelly Monk to study the variants in zebrafish. Third, I will discover antibodies
targeting the ECR of GPR126 and characterize them in functional assays. This proposal will result in a
mechanistic description of ECR-dependent regulation of GPR126 signaling, thus explaining how dysregulation
of this protein can contribute to disease. I will also produce antibodies which can be used as tools to probe
GPR126 function in disease models. This proposal is a multi-disciplinary and collaborative one, with great
training potential due to the span of techniques proposed, from structural biology to cell-based assays and
antibody discovery. In the Araç laboratory, I will be provided the opportunity to work with a world leader in
aGPCRs and to perform high-impact research on the molecular basis of adhesion GPCR signaling. I will expand
my skillset into structural biology of extracellular proteins, cell-based assays, and learn antibody discovery within
the lab of my Co-Mentor Dr. Kossiakoff. The University of Chicago and the Araç laboratory are world class
opportunities for me to develop the portfolio and skillsets for me to be competitive for faculty positions.

Public health relevance
Project Narrative Adhesion G protein-coupled receptors (aGPCRs) are understudied cell-surface receptors with multidomain extracellular regions that regulate development and they are dysregulated in developmental diseases and cancer. These receptors stand as the next generation of drug targets, yet drug development is hindered by the fact that the molecular basis of aGPCR function remains unclear. Using a combination of X-ray crystallography, cellular assays, and zebrafish experiments, this proposal will develop a structural and functional understanding of aGPCR regulation by the extracellular region using GPR126, a model receptor involved in nerve myelination and spinal development; this proposal also aims to discover antibodies targeting the extracellular region of GPR126, which will serve as probes to interrogate GPR126 function and possibly serve as leads for future drug molecules.